R35 Admin Diversity Supplement: Regulation of alternative splicing during epithelial-mesenchymal transition

ABSTRACT
The goal of this supplement is to support research training and career development of a Diversity
graduate student in Dr. Chonghui Cheng’s laboratory. The goal of the parent grant is to investigate
the regulation of alternative splicing by RNA binding proteins in epithelial-mesenchymal transition
(EMT), a developmental program that is associated with many types of diseases, including tissue
fibrosis and cancer metastasis. We have carefully crafted training plan, career development plan,
and mentoring plan that will enhance the student’s intellectual and technical skills and facilitate
his career development. The graduate student will: (1) Actively conduct his thesis project towards
understanding how RNA binding protein regulated splicing and translation intertwine to control
EMT; (2) Receive extensive experimental and computational trainings; (3) Gain collaboration and
leadership skills; (4) Submit predoctoral fellowships; (5) Generate research findings and
participate in writing for publication in peer-reviewed journals; (6) Attend and present in Scientific
meetings.

Public health relevance
PROJECT NARRATIVE This Diversity Supplement will provide funding to support the training of a diversity graduate student in Dr. Chonghui Cheng’s lab to become an independent and creative scientist. Research proposed under this supplement will be an integral part of the parent 5R35GM131876.